BINDING AND UPTAKE OF MOUSE IGA BY MOUSE GLOMERULAR MESANGIAL CELLS

IgA nephropathy is probably the most common form of human glomerulonephritis. Experimental IgA nephropathy, similar to the human disease, can be induced in mice using cross-linked DNP and mouse IgA anti-DNP. The mechanism of binding of IgA by mesangial cells was studied using mouse glomerular mesangial cells in vitro.